COMPARATIVE STUDY OF METERED DOSE INHALER IN PATIENTS WITH BPD

Effectiveness of metered dose inhaler vs. aerosolized albuterol in ventilator dependent patients with BPD. Mode of delivery and cost effectiveness for long term use will be studied.